Autopsy-informed integrated clinical and imaging models for prediction of non-AD co-pathologies in AD

PROJECT SUMMARY
The overall goal of this project is to use gold-standard autopsy-confirmed datasets to build computational models
with which widely available neuroimaging and cognitive assessments can be used to predict presence of non-
Alzheimer’s disease neuropathological changes (non-ADNC) in individuals with ADNC. Far from a rare problem,
estimates of rates of neurodegenerative co-pathology in patients with ADNC range from 50% to 100%. These
co-pathologies have been shown to influence the clinical progression of AD symptoms. Yet, biomarkers remain
mostly unavailable for non-ADNC, including Lewy body disease (LBD), transactive response DNA-binding
protein 43 (TDP-43) proteinopathy, and cerebral amyloid angiopathy (CAA). Without biomarkers to recognize
the presence and severity of these co-pathologies in individuals with AD, every clinical trial designed to show
the effectiveness of an AD treatment will continue to systematically underestimate the maximum therapeutic
effect of the drug. Better biomarkers to detect co-pathologies in ADNC cases are an essential precursor to
optimally treating AD. We will pursue the following specific aims: Aim 1: Develop precise machine-learning
based computational models that predict the presence of three major forms of non-ADNCs (LBD, TDP-43, CAA)
in individuals with ADNC using a single timepoint of in vivo multimodal neuroimaging and clinical data on a
Discovery Cohort of N=530 from the University of California San Francisco (UCSF) ADRC, the Alzheimer’s
Disease Neuroimaging Initiative (ADNI), and Religious Orders Study / Rush Memory and Aging Project
(ROS/MAP) by leveraging effort of the Alzheimer's Disease Sequencing Project Phenotype Harmonization
Consortium (ADSP-PHC). Aim 2: Increase model precision by adding clinical progression features from
Discovery Cohort longitudinal neuroimaging and clinical assessments to predict non-ADNC in individuals with
ADNC. The models will be optimized for real-world implementation by clinical researchers via performance
testing against a subset of NACC participants (N=365) and a non-autopsy cohort of 2000+ ADNI and DIAN
participants (Validation Cohort). We will examine to what extent clinical stage, timing of data collection, and
missing data affect the accuracy of model predictions, and create and disseminate tools based on these models
for all researchers to use. These models will rely heavily on the macrostructural brain changes seen on MRI, and
will integrate multimodal MRI sequences (T1, FLAIR) and FDG-PET, cross-sectional and longitudinal timepoints,
and clinical data, including neuropsychological testing and neuropsychiatry. Because biomarker development
requires validation against ground-truth data, key to this proposal is the harmonization of three highly detailed
and comprehensive autopsy-confirmed cohorts (Discovery Cohort) with enriched neuropathology, neuroimaging,
and clinical data. At the conclusion of this study, we will have for the first time established clinically translatable
computational models to predict the presence of TDP-43, LBD, and CAA co-pathologies at the single case level
in individuals with ADNC from imaging and clinical data.

Public health relevance
PROJECT NARRATIVE Mixed-pathology etiology is more common than single pathology etiology in dementia, with increasing number of combinations found with advancing age. The goal of this study is for the first time to establish clinically translatable computational models from brain imaging and clinical data to predict the presence of co-pathologies at the single case level in individuals with Alzheimer’s disease neuropathological changes. This work will support efforts of the scientific community to design trials to optimally treat Alzheimer’s disease.